HCV and co-morbid alcohol use disorders: a translational investigation of antiviral therapy outcomes on CNS function

Chronic hepatitis C virus (HCV) infection is often associated with extrahepatic manifestations, including
central nervous system (CNS) damage and neuropsychiatric impairments that can be exacerbated by
alcohol abuse. More than half of patients with chronic HCV infection complain of “brain fog” (impaired
cognition, fatigue). The introduction of direct-acting antiviral (DAA) therapies has revolutionized HCV
treatment, with sustained viral response (SVR) rates of ~90%. The VA is now offering DAA therapy to all
Veterans with HCV treated within VA health care systems, including those with alcohol use disorders
(AUDs)—a common co-morbidity among Veterans with HCV. Despite this progress and expansion in
HCV treatment efforts, there are insufficient data on brain function outcomes (e.g., outcomes that affect
daily life such as cognitive abilities, fatigue, and substance abuse behavior) following DAA therapy.
There are also limited data on the effects of viral clearance on inflammatory factors that putatively
influence neuropsychiatric function. This Merit Review project plans to conduct a longitudinal study of
adults (with and without AUDs) undergoing antiviral therapy for the treatment of HCV. Demographically-
matched comparison groups of Veterans without HCV (with and without AUD) will also be evaluated to
determine the relative contribution of HCV to outcomes that are affected by alcohol abuse. It is
hypothesized that adults with HCV and co-morbid AUDs may be at increased risk of persistent brain
dysfunction following DAA therapy. By comparing neuropsychiatric functioning, cortical activity, white
matter integrity, and immune response among Veterans with and without active AUD before and after
DAA therapy, results from this study are expected to determine the extent of improvement in brain
function (e.g., neural connectivity and cognitive abilities) and reduction in inflammation that is achieved
by successful completion of DAA therapy. Two specific aims are proposed. Aim 1 will evaluate the
impact of DAA therapy on CNS function in Veterans with HCV and will test the hypotheses that following
DAA therapy and obtaining an SVR, participants will show: i) improved neuropsychiatric outcomes (e.g.,
cognitive function, fatigue, mood), as compared to baseline (pre-DAA therapy), ii) restored functional
connectivity and disintegrity within white matter tracks that had detectable deficits at baseline, and iii)
normalization of immune activation profiles (e.g., decreased expression of inflammatory cytokines and
restored T cell phenotypes), as compared to baseline. Aim 2 will use general linear models to assess
whether change in the response (e.g., CNS functional outcomes) between post- and pre-DAA therapy
differs among the four groups—either due to AUD, HCV, or the potential interaction of these factors—to
determine the impact of an active AUD on neuropsychiatric, neuroimaging, and immunological outcomes.
Participants will be assessed at baseline and 12 weeks post-therapy. Evaluations will incorporate brain
imaging methods [i.e., resting state magnetic resonance imaging (MRI), functional MRI, and diffusion
tensor imaging] along with clinical and laboratory methods to determine the interactive effects of alcohol
use and obtaining an SVR on brain function and inflammatory processes. Clinical and laboratory data will
include: i) demographic and medical information, ii) neuropsychological measures of attention, memory,
and executive function, iii) neuropsychiatric symptom questionnaires (e.g., depression, fatigue), iv) urine
and oral fluid collection for medical laboratory tests, and v) blood sample collection for flow cytometry,
qPCR, and multiplex immunoassays to measure key immune factors, such as interleukin (IL) -1, IL-8,
IL-10, S100B, and C-reactive protein and for contribution to the VA Liver Disease Repository.
Collectively, the results from this project seek to identify biomarkers of brain recovery and inform targeted
treatment strategies that will maximize the long-term clinical benefits of HCV antiviral therapy.

Public health relevance
Chronic hepatitis C virus (HCV) infection is associated with diseases or conditions that affect organs other than the liver, including the brain. The introduction of direct-acting antiviral (DAA) therapies has transformed the treatment of HCV, and the VA is now offering DAA therapy to all Veterans with HCV treated within VA health care systems. To accompany this effort, studies are needed to evaluate the impact of DAA therapy and obtaining a sustained viral response on brain function and the implications of having an alcohol use disorder, a co-occurring disorder that may hinder recovery. Results from this study are expected to determine the extent of improvement in brain function (e.g., nerve cell connectivity and thinking abilities) and reduction in inflammation that is achieved by successful completion of DAA therapy. This new information will: 1) address a gap in our knowledge concerning the effects of alcohol use on brain function following DAA therapy, 2) delineate the role of a network of immune factors in the brain healing process, and 3) enable targeted treatments.